Supplement for temporal bone histological tissue scanning equipment

Project summary
This proposal is for the purchase of temporal bone histological tissue scanning equipment as a supplement to
the parent proposal, R01 DC012262, entitled “Spectro-temporal interactions in electric and acoustic auditory
perception”. The long-term goal of the parent proposal is to improve auditory and speech perception via cochlear
implants (CIs) and hearing aids, through a greater understanding of the basic mechanisms that contribute to,
and limit, the perception of speech in challenging acoustic conditions. The long-term goals of the parent project
will benefit greatly from the use of otopathological specimens. Our university is fortunate to have one of the three
largest human temporal bone laboratories in the US, housing a well-diversified collection of 2,252 human
temporal bones. Our plan is to use digitized human temporal bone slides to relate the behavioral and
neuroimaging results gathered under the parent grant with otopathological data, providing a unique opportunity
to relate our perceptual findings to the cellular level within the inner ear and thereby assess the pathological
underpinnings of altered speech perception. Our plan is to search the database of our otopathology laboratory
and select specimens of special interest to our research (from patients who have similar background as ones in
our clinical study: age- and sex- matched, with and without hearing loss). These specimens will be scanned
using a high-resolution, high-throughput tissue scanner, which will be acquired through this funding opportunity
(Zeiss Axioscan 7). We will then scrutinize the middle and inner ears of temporal bones for properties that relate
to the perceptual performance of patients with CIs and hearing aids. We will perform quantitative analysis of
cochlear hair cells, stria vascularis, spiral ganglion neurons, and dendritic distal cochlear nerve fibers. The
benefits of having digital versions of the archival temporal bones will extend far beyond the parent project and
beyond researchers at our institution, as these digital versions will protect the information from these
irreplaceable specimens from being damaged in the case of accidents or natural disasters. In addition, by making
the digitized collection of archival specimens widely available, they will become an invaluable long-term resource
to the wider clinical and scientific communities involved with auditory and temporal bone research, meeting one
of the fundamental objectives of the NIDCD Registry. The images will ultimately be made available to the
scientific community through NIDCD approved databases.

Public health relevance
Project narrative This supplement will enable the acquisition of a temporal bone tissue slide scanner that will benefit the long-term goals of the parent grant and will also provide long-term and sustained benefits to the wider scientific community by making the digitized images available via NIDCD-approved databases. We will use high-resolution images of otopathological specimens, acquired with the slide scanner, to relate cellular and neural abnormalities affecting the organ of hearing (cochlea) to perceptual and neuroimaging results in patients with hearing loss and/or cochlear implants. The resulting creation of a digital repository of human temporal bone tissue will have a broader positive impact in otologic research, as these collections of archival human temporal bones will become digitally available to the scientific community, facilitating future collaborative studies.